Accessible Eye Tracking Solution for Assessment of Cognitive Deficits in Alzheimer's Disease

PROJECT SUMMARY
Millions of Americans currently suffer from Alzheimer’s disease, and the number is expected to escalate rapidly
in the coming years. The disease prevalence has a significant financial and emotional impact on families,
caregivers, and the healthcare system as a whole. Although there is currently no cure for Alzheimer’s, early
disease detection and diagnosis of the disease can provide an opportunity for treatment and management
strategies to enhance quality of life. Current assessment methods are either invasive, non-objective, or not
available to the masses, and therefore fail to meet the use and capability requirements we need. An individual’s
eye movement quality is an objective neurological heath indicator, but assessment has been limited to clinical
visits with specialized equipment and training, and therefore has received limited adoption. This project will
remove those limitations by producing an assessment that will utilize commonly available mobile device
hardware and real-time data analysis to track and measure eye movements.
The objective of this project is to develop an application that utilizes integrated mobile device cameras and
algorithms to measure eye movement that can be used to assess and monitor age- and Alzheimer’s Disease
related conditions. The measures from the mobile app will be compared to a hardware-based eye tracking
system to determine the reliability and validity of the measures.
Successfully completing these aims will result in an accessible tool that can effectively assess eye movement
quality. The high accessibility, distribution, and usability of our application will provide an opportunity for early
detection, therapies, and awareness of additional markers for the millions that currently are or are expected to
suffer from Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE This project will address the need for an accessible assessment to assist in early detection and treatment of Alzheimer’s disease. Eye movements are objective neurological health indicators, but current assessment methods require specialized equipment and training to administer. Completing the project aims will result in developing and validating a functional eye-tracking assessment that can be performed on a standard mobile device and reliably measure oculomotor variables that are associated with Alzheimer’s disease decline.